Integrating Hypertension and Cardiovascular Disease Care into Existing HIV Service Package in Botswana (InterCARE)-Statin Sub-study

PROJECT SUMMARY
While Botswana has attained the UNAIDS 95-95-95 target for HIV treatment and is the first country with
severe HIV epidemic to reach the milestone of elimination of mother-to-child HIV transmission, there is a
growing concern about long-term risk of non-communicable diseases among people living with HIV (PWH).
In 2022, a large international study (that included Botswana) focussed on prevention of heart attacks and
strokes, called REPRIEVE, revealed that use of cholesterol lowering medicines (statins) such as
Pitavastatin© can reduce the risk of heart attacks and stroke among PWH. The US department of human
and health services has since released a guideline for use of statins among PWH. Similarly, the British HIV
clinicians society issued a similar, but easier to implement statin guideline for PWH. Thus, in the proposed
research, we will develop and test new strategies that target PWH plus diagnosis of hypertension to be
initiated on statin therapy. Our proposed study will leverage a study of PWH and hypertension in Botswana.
The program will be developed in collaboration with policy makers, healthcare providers, community leaders,
patients, etc in Botswana. Following initial engagement with different informants, we will then use the new
implementation strategy to conduct a type 2 hybrid multi-component cluster randomized trial to optimize
evidence based implementation (EBI) uptake of statin therapy.

Public health relevance
Limited uptake of statins is a significant contributor to ongoing increased risk of cardiovascular diseases among people with HIV (PWH) and hypertension (HTN) in sub-Saharan Africa (SSA). Our proposed study, to be conducted in Botswana, will leverage a successful national ART program and infrastructure to first finalize implementation strategies for statin integration into integrated HIV/HTN (40-75 years old) to increase statin uptake, reduce barriers due lipid testing and use of CVD risk calculators. Based on lessons learnt from the current InterCARE study, we will then assess if InterCARE statin sub-study will enhance preventive primary care cardiovascular protection for PWH/HTN compared to the way it is currently being offered in Botswana.